Theory and Modeling of Functional Conformational Changes of RNA Polymerases

Project Summary: The operation of RNA polymerases (RNAPs) relies on numerous conformational changes.
During eukaryotic transcription, RNA Polymerase II (Pol II) encountering oxidative lesions in its DNA template
often leads to misincorporation and transcriptional stalling. These events contribute to tumor growth in skin
cancer. Mycobacterium tuberculosis (Mtb) causes lethal tuberculosis and is responsible for over 1 million deaths
per year. Transcription initiation complexes of Mtb RNAP, especially the DNA loading gate, are effective targets
for the development of antibiotics. Revealing the dynamics of transcription initiation can thus provide novel
mechanistic insights into prokaryotic transcription and greatly facilitate the understanding of inhibition
mechanisms for antibiotics targeting Mtb RNAP. These two important biological problems in transcription drive
us to develop novel methodology using the generalized master equation (GME) to model biomolecular
conformational changes. My group has been successful in developing GME methods that explicitly consider the
memory functions of biomolecular dynamics and outperform the popular Markov State Model (MSM) method.
However, as an emerging approach, the current implementation of GME is prone to instability when estimating
memory functions for complex RNAP systems. We here propose novel methods to build GME models. Our
specific aims are: 1. To develop new GME methods to model conformational changes. Specifically, to derive a
new theory (IGME) to solve the GME, to develop efficient implementations of the GME to enhance numerical
stability when computing memory kernels from molecular dynamics (MD) simulation trajectories, and to create a
protocol tailor-made for building GME models to study biomolecular conformational changes. Our preliminary
work shows that the proposed IGME method greatly outperforms the original implementation of GME in yielding
robust and accurate predictions of the biomolecular dynamics, especially for the complex RNAP system. 2. To
reveal how the dynamic coupling of several key conformational changes (i.e., the loading of NTP, the rotation of
the damaged DNA base, and the translocation of Pol II on the DNA template) leads to transcriptional
mutagenesis and/or stalling. Specifically, to construct GME models to elucidate molecular mechanisms of 8-oxo-
guanine (8OG) and Guanidinohydantoin (Gh) lesions induced ATP misincorporation and/or transcriptional
stalling. 3. To elucidate the molecular mechanisms of transcriptional initiation and its inhibition of Mtb RNAP.
Specifically, to construct GME models to reveal the dynamics of the Mtb RNAP’s loading gate without DNA, and
to further reveal the dynamics for the transition from a partially formed transcription bubble to a fully formed
bubble, a conformational change involving both Mtb RNAP’s gate opening and DNA unwinding. We further aim
to understand the recognition mechanisms of multiple antibiotic compounds, including Myxopyronin (Myx) and
Fidaxomicin (Fdx) that target the loading gate motion, and Sorangicin (Sor) that inhibits the formation of the full
transcription bubble. These mechanistic insights will facilitate the rational design of new inhibitors fighting drug
resistance of Mtb in the long term. Throughout our studies, we will work closely with our experimental
collaborators to conduct biochemical, time-resolved X-ray, and Cryo-EM experiments to test and validate our
predictions. Our innovative GME methods will provide a general computational framework to model functional
conformational changes of biomolecules. Our developed protocol and associated code development in the
MSMBuilder software will widely benefit the biophysics community.

Public health relevance
The computational methodologies we develop will be applicable to a broad range of conformational changes of RNA polymerases with biomedical relevance. In particular, oxidative DNA lesions cause transcriptional mutagenesis of RNA Polymerase II that contributes to tumor growth in skin cancer, and mechanistic insights from this work will help uncover a route to address the adverse effects of these DNA lesions. In addition, antibiotics against Mycobacterium tuberculosis (Mtb) often target the dynamic motion of its RNA polymerase, and this work will provide mechanistic insights to facilitate the rational design of new antibiotics fighting drug resistance of Mtb.